CHAIRS-C: Climate, Health, and Aging Innovation and Research Solutions for Communities

Extreme temperature, humidity, and particulate air pollution are threats to human health, the frequency of
intense exposure to these threats is increasing, and their combination particularly impacts aging populations
and those with chronic health conditions. To combat these challenges, we propose establishing a new center at
Brown University, “Climate, Health, and Aging Innovation and Research Solutions for Communities (CHAIRS-
C),” to advance science on the adverse health implications of climate events and develop actionable solutions
to promote healthy aging for all. CHAIRS-C will be comprised of an Administrative Core, Research Project,
Capacity Building Core, and Community Engagement Core, all designed to efficiently bring together a breadth
of existing and emerging climate and aging research with critical community partners. The long-term objectives
of CHAIRS-C are to enhance relationships between Brown University and community partners and strengthen
interdisciplinary research among existing campus-based units. CHAIRS-C intends to be a national leader in
understanding the impacts of climate change on older adults and proposing innovative interventions to mitigate
these harmful effects. To achieve these long-term objectives, CHAIRS-C has identified the following specific
aims: 1) Strengthening and expanding multi-directional engagement of academic, community-led, and
governmental partners around climate-related risks and accessible mitigations for aging populations; 2)
Developing new capacity for transdisciplinary research and community engagement in climate and health
through shared learning experiences, focused on aging populations; and 3) Sharing findings from best-
available exposure modeling and place-based health datasets with community and governmental partners to
stimulate actionable, localized responses, particularly for high-risk subgroups facing disparities. The basic
tenet of CHAIRS-C is that innovative solutions require partnerships between communities and researchers to
generate the appropriate evidence and political will to guide effective and efficient solutions. Neither research
nor community action is effective alone. To mitigate the adverse implications of climate change, we must
collaborate. CHAIRS-C will merge these approaches to benefit older adults, setting a new standard that will be
applicable to other populations facing inequity and health threats related to climate change.

Public health relevance
Narrative We propose developing a new center at Brown University named “Climate, Health, and Aging Innovation and Research Solutions for Communities (CHAIRS-C)". The theme of this center is to study how climate-related exposures such as heat and air pollution impact the health of older adults. Working in partnership with community groups and governmental organizations, we will form transdisciplinary collaborative teams to develop evidence and actionable solutions to promote healthy aging for all.